Data Coordinating Center for the Type 1 Diabetes in Acute Pancreatitis Consortium

PROJECT SUMMARY / ABSTRACT
Type 1 diabetes mellitus (T1D) may develop after, or as a consequence of, one or more acute pancreatitis
episodes. Elucidation of early biomarkers, clinical signs, biomarkers of disease progression, immune and
genetic risk factors, most susceptible subgroups, precipitating mechanisms, etiology of acute pancreatitis, and
associated pathophysiology of the T1D can help inform best practices in treatment for reducing incidence of
T1D onset. In 2020, the National Institute of Diabetes and Digestive and Kidney Disease (NIDDK) formed the
Type 1 Diabetes in Acute Pancreatitis Consortium (T1DAPC), consisting of 10 Clinical Centers (CCs), along
with three satellite centers, and one Data Coordinating Center (DCC). The T1DAPC has developed an
observational prospective cohort study, titled “Diabetes RElated to Acute Pancreatitis and its Mechanisms
(DREAM).” The DREAM study is enrolling adults with a recent episode of acute pancreatitis (AP) to
characterize and understand diabetes mellitus (DM) that develops following AP. The DREAM study will enroll
1200 individuals with the anticipation that up to 800 participants will enter longitudinal follow-up. As of
November 2024, the DREAM study has enrolled 806 participants, 459 of whom have entered the longitudinal
follow-up phase. The DREAM study has three specific aims: (1) Determine the cumulative incidence and clinical
characteristics associated with the development of DM after one or more episodes of AP; (2) Comprehensively
characterize beta cell function and endocrine alterations after AP and their relationship with the development of
DM after AP; (3) Determine the immunologic mechanisms of DM after AP, including the contribution of β-cell
autoimmunity. The NIDDK has issued RFA-DK-25-017 and RFA-DK-25-018 for the T1DAPC Principal
Investigators to continue the DREAM study during the period 2025-2030. In response to RFA-DK-25-018, the
Departments of Public Health Sciences (DPHS) and Medicine at the Penn State College of Medicine propose
to continue serving as the DCC for the T1DAPC. The nine specific aims are as follows: (1) provide overall
logistical support for the activities of the T1DAPC Steering Committee (SC) and its subcommittees and working
groups; (2) support all the administrative, regulatory, managerial, logistic, analytic and financial functions for
accrual and longitudinal observation of T1DAPC patients; (3) provide training and technical assistance to the
CC in the course of their implementation of protocols; (4) collect, curate, manage and store all study data and
provide it as needed to consortium members to support publications; (5) manage subawards for patient costs,
biospecimen analysis and other tasks as needed; (6) develop, support and manage the T1DAPC biobank to
process, safeguard and distribute the study biospecimens; (7) design and support new studies for the conduct
of studies approved by the T1DAPC SC; (8) prepare reports and presentations for the T1DAPC’s DSMB and to
collate replies to their questions; (9) prepare and transfer all study data and biospecimens to the NIDDK
Central Repository at the close of the study.

Public health relevance
PROJECT NARRATIVE Acute pancreatitis is an acute inflammatory process resulting in damage to pancreatic parenchyma with an annual incidence ranging from 5 to 45 cases per 100,000 persons. Recent studies indicate that • 30-40% of patients develop diabetes mellitus or impaired glucose tolerance within three to four years of even a single episode of acute pancreatitis • the autoantibodies associated with Type 1 diabetes (T1D) are found in people with a history of pancreatitis, indicating that pancreatitis-related diabetes poses long-term burden and significant risk of comorbidities as frequently as in other patients with diabetes The Type 1 Diabetes in Acute Pancreatitis Consortium (T1DAPC) has designed a prospective observational study to investigate the incidence, etiology, and pathophysiology of diabetes following acute pancreatitis with an emphasis on the auto-immune processes that result in T1D as well as the incidence, time course, and relationship to pancreatitis severity, the roles of pancreatitis etiology, genetic and genomic risk factors, environmental and biological factors, and potential biomarkers for the development of T1D.